Design, synthesis and application of long wavelength fluorophores for bioimaging

Project Summary
Neurons and cardiomyocytes utilize rapid changes in membrane potential for cellular signaling. Understanding how
changes in membrane potential affect cell behavior across a population of neurons or cardiomyocytes is an important
challenge in biology. Widely used techniques to measure membrane potential, either directly or indirectly, consist of patch
clamp electrophysiology and calcium ion imaging agents. Using patch clamp electrophysiology to measure membrane
potential results in accurate measurements of membrane potential on the timescale of the action potentials. However, these
experiments are limited to a single cell membrane, which precludes using patch clamp electrophysiology to study larger cell
populations. Calcium ion imaging agents are widely used, as it has a higher throughput and is less invasive than patch clamp
electrophysiology. By measuring temporary changes in calcium ion concentrations, we are able to indirectly measure
changes in membrane potential. Unfortunately, a major drawback in this technique is the long durations of calcium ion
uptake (10-100 ms) found during a neuronal action potential, which is significantly longer than the actual action potential
itself (1-2 ms). This our ability to understand cell behavior and how it relates to these rapid signaling events.
To address this challenge, our group has developed several different fluorescent probes called VoltageFluor dyes to
measure these rapid changes in membrane potential. The VoltageFluor dyes consist of a fluorescent xanthene core tethered
to a hydrophobic molecular wire. The molecular wire localizes in the cell membrane while the xanthene core orients itself
in the extracellular space. Using this system, we can measure rapid changes in membrane potential in large populations of
cells on the same time scale as the action potentials themselves.
While our previous VoltageFluors work as intended, we wish to develop new VoltageFluors that emit light in the near
infrared. A red-shifted emission spectrum would allow these VoltageFluor dyes to be used in vivo as well as in conjunction
with other indicators that emit light at <600 nm. To accomplish this goal, we will develop new VoltageFluor dyes that
contain electron withdrawing groups in the xanthene backbone. In accordance with Dewar’s rule, the inclusion of electron
withdrawing groups will result in a red-shifted absorption and emission spectra. This hypothesis is supported by
computational studies we have undertaken. The planned syntheses of these xanthene cores will also be more robust and
tolerant of various functional groups than the syntheses of our previous dimethylcarbon and dimethylsilicon VoltageFluor
dyes.
In comparison to our previously synthesized VoltageFluor dyes that utilize a dimethylcarbon and dimethylsilicon
backbone in the xanthene core, the electron withdrawing groups found in the proposed VoltageFluors offer new functional
handles that can easily be diversified. This expands the range of applications that these dyes can be utilized for, including
tethering triplet state quenchers to the xanthene core and using genetic targeting techniques to localize these VoltageFluors
in specific cells. We also anticipate that the facile diversification of the xanthene core will mean that these dyes will be more
broadly applicable. By synthesizing these dyes without the molecular wire, we also anticipate that we will be able to use
this technology in calcium ion imaging studies.

Public health relevance
Project Narrative VoltageFluor dyes are fluorescent indicators that can be used to measure changes in potential across cell membranes in large populations of cells in ways that are not possible with standard techniques such as patch clamp electrophysiology and calcium imaging. By synthesizing a new class of xanthene dyes that contain a significant red-shift in their emission spectra, we will be able to expand the utility of these VoltageFluor dyes. The ability to diversify these new dyes will allow for their application to several different systems, including genetically targetable dyes, triplet state quencher-stabilized dyes and calcium imaging.